Linking retinal circuits to perception

Therapeutic tactics under development to restore sight to the blind rely on stimulating elements in the human
retina where more than 50 different types of neuron are organized into specialized circuits, some of which
mediate conscious perception, while others serve non-imaging forming functions, such as circadian
photoentrainment and guiding motor movements. However, there is little agreement about which of the more
than 20 ganglion cell types are responsible for specific visual functions. Similarly, little is understood about the
retinal circuits contributing to the diverse tasks outside the human perceptual experience. These represent
fundamental gaps in knowledge that must be filled to provide information necessary to guide efforts to preserve
or restore visual functions such as object recognition without inadvertently interfering with essential non-image-
forming functions. Thus, the long-term objective of the work proposed here is to fill these gaps in knowledge by
making tangible progress on two key issues.
First, the ability to see and recognize objects requires a diversity of cells carrying different information to
specific brain areas involved in conscious vision. For example, the shapes and boundaries of objects in a
visual scene are represented by the percepts of black, white, shades of gray, and color. Specific Aim 1 is to
test the hypothesis that previously unappreciated features of the midget circuitry, both in the inner and outer
plexiform layers, carry out the initial computations responsible for color and black and white vision, and that
this is done by circuitry that separates midget ganglion cells into six types corresponding to the sensations of
red, green, blue, yellow, black, and white, each of which are associated with signaling surface reflectance, not
merely the spectral properties of light in the retinal image.
Second, 3D reconstructions of primate retina using serial block face scanning electron microscopy (SBFSEM)
have revealed an unexpected diversity and quantity of retinal ganglion cell types carrying short-wavelength (S)
cone signals. The S-cone connectome includes redundant color-coding ganglion cells that project to many
brain areas providing the same color information for a broad range of functions besides conscious color vision.
Specific Aim 2 is to gain a complete understanding of all the types of retinal ganglion cells carrying S-cone
signals in the primate retina, the circuitry responsible for their response characteristics, and the role each plays
in guiding our behaviors. This will be done using SBFSEM and single-cell electrophysiology.

Public health relevance
Technological advancements in stem cells, gene therapy, and retinal prostheses show great promise for restoring or providing new light sensitivity to retinas of the blind; however, understanding of the basic circuitry for daylight vision lags behind the technology to provide light sensitivity. There is an urgent need to elucidate the circuitry of visual pathways and to understand their role in visual perception in order to identify the best therapeutic strategies and the most effective implementations of them.